Testing Multi-Level Remote Physical Activity Interventions in a National Sample of Older Women: The WHISH EnCore Trial

Project Summary/Abstract
Older women are disproportionately impacted by a range of chronic diseases and conditions, such as
cognitive impairments, that can be alleviated by regular physical activity (PA), including walking; yet they
are the most inactive segment of the US population. While the majority of older women use smartphones,
few remotely delivered PA interventions have been developed specifically to address this age + gender PA
disparity, and few such interventions leverage built and social environmental factors that can increase daily
PA. Using a dynamically based socio-ecological model of health behavior change, this study’s primary aim
is to enhance the efficacy of a “light-touch”, remotely delivered PA educational intervention for older women
by testing the added impacts of an innovative, remotely delivered citizen science program to identify and
address local environmental barriers to walking and other PA (called Our Voice TM [OV]). The “light-touch”
PA educational program has been delivered since 2015 to >23,000 women >70 years that have been
participating in the U.S.-wide Women’s Health Initiative Strong and Healthy (WHISH) pragmatic PA trial
(U01HL122280-03). WHISH, which used a pragmatic, ‘opt-out’ consent enrollment process, includes the
broadest range of PA, physical function levels, and geographic regions found in PA intervention studies to
date. The original WHISH educational program has resulted in significant but generally modest PA increas-
es in the overall WHISH population, and surveys indicate that many WHISH participants could benefit
strongly from further intervention. An enriched version of the original remote program (called enCore) will
serve as the enCore Alone arm in the proposed trial. To address local built and social environmental PA
barriers that many WHISH women describe, the mobile app plus web based OV program will be added to
enCore (enCore+OV arm). We will randomize a total of 300 WHISH intervention women (mean age=85
yrs.) with smartphones who are insufficiently active to the two arms. We hypothesize that women receiving
enCore+ OV will show higher pedometer-measured 12-month PA levels than women receiving enCore
Alone. Additional questions include changes in cognitive function and sedentary behavior; exploring a theo-
retically derived multi-level set of putative mediators (e.g., social cohesion, rated neighborhood walkability,
community wayfinding) and baseline moderators of program success (e.g., race/ethnicity, family support,
geographic region); and exploring the relative costs of the two programs for PA change. The study will add
important information on the benefits and trade-offs of combining these remotely delivered, practical, and
potentially scalable behavioral health delivery approaches for this fast-expanding demographic group.

Public health relevance
Project Narrative While older women are disproportionately affected by chronic diseases and conditions associated with aging, including both physical and cognitive impairments, that can be alleviated or delayed by regular physical activity, few physical activity programs have been developed specifically with their needs in mind. This research aims to evaluate, in insufficiently active older women from the national WHISH pragmatic trial, the added effects of a technology-driven environmental barriers intervention called Our Voice compared to a “light-touch” remote educational program alone that has been delivered as part of WHISH. This study will add important information on the benefits and trade-offs of combining these remotely delivered and practical behavioral health delivery approaches to promote physical and cognitive health for the fast-expanding demographic group of U.S. older women.